Epigenetic regulation of chromatin by the Keap1-Nrf2 xenobiotic response signaling in Drosophila

Epigenetic regulation of chromatin by the Keap1-Nrf2 xenobiotic response signaling in Drosophila
ABSTRACT
Conserved oxidative and xenobiotic response factors protect cells from damages caused by internal or
external toxins. How these factors mediate the adaptation to constant environmental toxins is largely unclear.
Epigenetic modifications are essential mechanisms that can mediate long-term adjustments of transcription
profiles in responses to environmental changes. Understanding the relationship between xenobiotic response
factors and epigenetic machineries will help elucidate the molecular mechanisms that mediate epigenetic and
developmental adaptations to environmental toxins and help understand the effects of environmental toxins to
human health.
The Keap1-Nrf2 signaling pathway is essential for oxidative and xenobiotic responses and is related with
many diseases especially cancer. Supported by the previous R15 grant, my laboratory assessed the novel
functions of Drosophila Keap1 and Nrf2 homologous proteins, dKeap1 and CncC, in the regulation of
chromatin structure and developmental transcription. We found that dKeap1 and CncC can control both
heterochromatin and euchromatin through interactions with specific partners such as lamin and NURF. In this
renewal proposal, we plan to comprehensively characterize molecular and biological interactions between
dKeap1/CncC and chromatin remodeling proteins including A-type and B-type lamins, actin, NURF, and JIL-1.
We will also employ an established dKeap1 “chromatin-off” mutant to fully identify developmental genes that
are directly targeted and regulated by the chromatin-binding dKeap1 in a redox-independent manner. Finally,
we will test the hypothesis that dKeap1 and/or CncC mediate developmental adaptations to xenobiotic
compounds through epigenetic regulations of chromatin architecture in the nucleus.
The proposed research is also expected to strengthen undergraduate educations in both the classroom
and laboratory. The research aims can be divided into various sub-projects, which will either be introduced into
undergraduate lab courses Molecular Biology Lab and Experimental Biology, or be used to support graduate
thesis and undergraduate research in Deng laboratory. Through participating original research driven by
hypothesis, students will acquire strong research experience on biomedical sciences.

Public health relevance
PROJECT NARRATIVE Elucidating epigenetic functions of xenobiotic response factors will help understand mechanisms that mediate long-term transcriptional adaptations to environmental toxins. We will apply fluorescence imaging, molecular, and genetic analyses in Drosophila to assess how Keap1-Nrf2 xenobiotic response factors regulate chromatin architecture through interactions with different chromatin modifiers, and how these detoxifying factors mediate epigenetic and developmental responses to xenobiotic stimuli. This work will provide insights into how environment toxins shape development and cause diseases at the molecular level.